Development of a CDISC Therapeutic Area Standard for Lung Cancer

Principal Investigator (Last, First, Middle): Kisler, Bron Witt Development of Oncology – Lung Cancer Data Standard Project Summary The objective of this project is to develop a global, non-proprietary data standard for Lung Cancer, utilizing the CDISC standards development process and the CDISC SHARE Metadata Repository. This project will lead to the development of specifications for that Therapeutic Area, which capture how to structure commonly collected data and outcome measurements in disease clinical trials. The Specific Aims of this project are: • Develop data standards for Lung Cancer clinical research studies using the CDISC standards development process. • Ensure alignment with the CDISC Study Data Tabulation Model (SDTM) for FDA electronic submissions • Code applicable oncology Concepts and controlled terminology in the NCI EVS terminology system • Use the CDISC SHARE Metadata Repository and other tools to support development of the Lung Cancer data standard. • Publish a Therapeutic Area Standard for Lung Cancer and make it publicly available via the CDISC Website. This project will be accomplished through several distinct stages in conjunction with major enhancements to the standards development process: • Stage 0 – Initiation and Scoping: Review and approval of project proposal and define scope. • Stage 1 – Identification a n d m o d e l i n g of CDISC Concepts: Create multi- disciplinary core team (including FDA contact), review available prior work, design concept maps, create new concept map templates, and perform gap analysis with existing CDISC constructs. • Stage 2 – Development of Draft Standards: Core team develops detailed metadata for SHARE in SDTM format, draft user guide. Education Content is developed in conjunction with Standards Development experts. • Stage 3a – Internal Review: Review of draft standards by relevant CDISC teams and experts in Lung Cancer. • Stage 3b – Public Review: Review of draft standards by general public for a minimum of 30 days, approve as a final production standard. • Stage 3c – Public Release: Data standard posted to CDISC website. • Develop Educational content specific for the Lung Cancer Standard oncology domains to educate users. • Throughout all stages, work with the SHARE team to determine tools to efficiently develop therapeutic area standards and improve availability of metadata in electronic format.

Public health relevance
Principal Investigator (Last, First, Middle): Kisler, Bron Witt Development of Oncology – Lung Cancer Data Standard Project Narrative The FDA has listed Lung Cancer as a priority research area due to the amount of deaths per year and the amount of funding spent to treat cancer. CDISC Standards provide a solution that can lead to significant cost savings by accelerating delivery of new therapies to treat Lung Cancer. According to the American Institute of Cancer Research (AICR), approximately $895 billion is spent on cancer annually, costing more money than any other disease. Cancer accounts for the biggest financial impact in terms of loss of life and productivity, matching 1.5% of global gross domestic product (GDP) losses. Improved strategies are needed to shorten the time required to identify genuine therapeutic advances and make them available to patients. Developing a Therapeutic Area Standard for Lung Cancer will provide a greater opportunity for science and technology breakthrough; it will transform patients’ health.